Delaware Center for Musculoskeletal Research – Multiscale Assessments Research Core

Project Summary / Abstract
The Delaware Center for Musculoskeletal Research (DCMR) will support basic and preclinical research on
the central theme of musculoskeletal health and disorders, from the level of the entire body to the molecule, with
an emphasis on the mechanisms by which physical and biological cues influence tissue structure and normal
function, dysfunction, and potential therapeutic interventions. Unraveling the interconnected responses at
multiple levels will require an integrated application of advanced biomechanical and bioimaging techniques with
preclinical (animal) and biophysical (explant) model systems. This requirement is not easily met using standard
instrumentation typically available in research centers, and state-of-the-art equipment, technical expertise to use
this equipment, and scientific expertise across multiple platforms to guide the design and application of these
techniques is needed.
The goal of the Multiscale Assessments Research Core is to maximize the success and impact of DCMR
Research Project, Project Leaders, and other researchers by providing a Research Core that includes state-of-
the-art equipment to apply and assess physical cues and biological signals. The Core will use a gateway
organizational framework that is built around interlinked scientific leadership, technical expertise, user training,
and partnerships with existing collaborative Centers. The Research Core will provide, develop, and support
multiscale mechanical loading and measurement capability, expertise, and training (Aim 1); provide, develop,
and support preclinical and biophysical models, including assessment capability, expertise, and training (Aim
2); and enhance the existing Bioimaging Center (Aim 3).
The Research Core will obtain new state-of-the-art equipment, including the construction of new instruments
to apply physical cues and molecular signals to living systems and the purchase of advanced instrumentation
for in vivo imaging. The Research Core will be housed in a newly renovated 1400 sq. ft. lab space adjacent to
the vivarium. The coordination of musculoskeletal resources and expertise in the DCMR Multiscale Assessments
Research Core will accelerate the research pace for Project Leaders and Center users. The use of Core’s
resources for research questions at the interface of engineering and life sciences will have a synergistic effect
that will strengthen UD’s biomedical research infrastructure and impact.